System for unitary automation of library preparation

Project Summary
Redbud Labs is developing an automated microfluidic system for next-generation sequencing
(NGS) library preparation, aiming to eliminate a persistent bottleneck in the sequencing
workflow. The system improves speed, reliability, and throughput of sample prep, particularly for
low-input and FFPE samples common in translational and clinical research. This innovation
builds on Redbud’s core microfluidics technology and is supported by its active Phase II SBIR
grant (2R44GM145194-02A1).
To ensure successful market entry, Redbud seeks a TABA Administrative Supplement under
PA-20-272 and NOSI NOT-OD-24-077. The company will engage i5 BioPartners, a
commercialization firm with deep experience in life science tools and direct expertise in NGS
workflows, to provide third-party assistance. The proposed project includes three high-impact
activities: (1) structured voice-of-customer (VOC) interviews and market segmentation; (2)
development of a strategic messaging and positioning framework; and (3) creation of
commercialization collateral including a brochure, technical white paper, and website content.
These activities fall within the NIH-defined categories of Market & Commercial Strategy and Go-
to-Market Execution. The requested TABA funding of $48,000 will enable Redbud to refine
product-market fit, strengthen its go-to-market approach, and support early adoption efforts—
none of which are covered under the original Phase II award budget. All work will be conducted
during the active grant period (Oct 1, 2025 – Mar 31, 2026).

Public health relevance
Project Narrative This TABA supplement will support the commercialization of an automated microfluidic system for NGS library preparation, a critical step in genomic analysis. By enabling reliable, hands-free sample prep for low-input and FFPE samples, the technology will improve access to sequencing-based diagnostics and research tools. The requested support will accelerate market readiness and adoption of this innovation in clinical, translational, and biomedical research settings.